Genomic Competency Initiative

Project 1-Nursing Capacity in Pharmacogenomics: The national study of advanced practice nurses assessing pharmacogenomic capacity is being done collaboration with Dr. Cathy Fulton at Indiana University. The instrument was pilot tested and the protocol approved as Exempt at Indiana University and the NIH 000990. The study recruited participants from the Coalition of Advanced Practice Registered Nurses of Indiana (CAPNI) and the American Association of Nursing Practitioners annual meeting. CAPNI, disseminated the survey electronically will end recruitment in August 2022. Once CAPNI completes recruitment data analysis will begin. Thus far we been unsuccessful in having the American Association of Colleges of Nursing disseminate a faculty specific pharmacogenomic survey. We are exploring other mechanisms to gather faculty data on pharmacogenomic capacity and curricular content. Project 2-Omics Nursing Science and Education Network (ONSEN): The National Institute of Nursing Research (NINR) Director has changed. The current director changed NINR reserarch priorities to not include genomics or other biologic correlatives. The new strategic plan reflects this direction and NINR funding for studies that include biologic correlatives has been discontinued as has the Summer Genetics Institute (SGI). The intramural symptom science investigators have left NINR. Funding for the ONSEN was discontinued and the website is being taken down though I have navigated moving the website to the University of Pittsburgh (UPitt). The National Human Genome Research Institute (NHGRI) asked me to update the Genomic Nursing Science Blueprint. I discussed that NINR will not participate and there is no mechanism to both train nursing scientists to integrate genomics into their research nor a funding stream to support this work. NHGRI asked the NINR Director to speak at Council and Drs. Brody and Green plan to meet with her in follow-up given concerns they have and I have met with Dr. Brody at his request to provide some background information. I am moving forward with the Blueprint on a global scale through G2NA (Project 3) and will work with UPitt to expand ONSEN for global use. If there is a US funding stream for genomic nursing science (many are symptom science) then I will explore mechanisms for regenerating the Summer Genetics Institute as a possible NCI/NHGRI collaboration. Project 3-Global Genomics Nursing Alliance (G2NA): G2NA, established in 2017 has grown to 146 nursing leaders. The G2NA website https://g2na.org/ has funding and support from the University of South Wales (USW); sustains quarterly education webinars; grown the countries represented; established a strategic plan; communicates through a listserv; completed or are conducting research projects described below. Three Communities of Practice received the most votes from G2NA constituents to move forward: Workforce Development; Clinical Practice; and Overcoming Barriers. However, the pandemic has slowed the launch. The current action plan is to launch one and evaluate success. Two primary research outputs from G2NA, the Roadmap and the Maturity Matrix have both been adopted by England National Health Service and Health Education England in their country wide genomic implementation initiative. This effort is still in the early phases, i.e. the faculty training program was July 2022 despite being planned 3 years ago. As this implementation moves ahead, large scale usability data on the Maturity Matrix and Roadmap will be conducted to refine both tools. Establishing a Global Genomic Nursing Science Blueprint is still in place but delayed. This project starts with a systematic evidence review with a doctoral student from USW working with me. She had both personal and health problems but is finally back at it. But we needed an updated search. The first 6388 papers have had abstract reviews. The second updated search is in Covidence and there are 5 reviewers. 995 new abstracts need review, 331 have 1 vote and 490 full text in Covidence need review. The plan is to have the remainder of abstracts/papers reviewed by October 1. The doctoral student will coalesce the evidence at which time G2NA will convene a panel to establish a Global Genomic Nursing Research Blueprint. The project to establish the Global Minimal Genomic Competencies for nurses and midwives was unable to move ahead in this reporting period due to COVID as panelists include academic educators who had to transition to and back out of remote education. Methods have been established and the project now will launch late fall 2022 or spring 2023. Lastly, a team from Finland, United Kingdom, Canada and myself a COST Action European Union grant which provides funding for European and global research and capacity building initiatives. This will be submitted 10/2022 with 15 country partners besides the submission team. If funded, this will facilitate the ability to convene the meetings for establishing the Blueprint but also a research consortium and genomic capacity building initiatives and establishing evidence-based best practices and a resource toolkit. Project 4-The Genomic Nursing Competency (GNC) Update: With my collaborator Laurie Badzek, we submitted a proposal to the American Nurses Association for a national nursing precision health and genomic competency initiative which was approved and has launched. The previously updated but not published Genomic Nursing Competencies will be disseminated for public comment in August 2022. Changes will be integrated, and ANA will digitally publish them followed by integration into Scope and Standards of Practice so the existence of Competencies will no longer be required. ANA is also supporting the update the Genetic and Genomic Competencies for Graduate Nurses. This will use the same methodology as the original competency update, a Delphi study. The Delphi reviewers have been selected and the list approved by ANA. Invitations will be go out September, 2022. The Delphi Survey will launch once the Delphi panel is fully populated. Competencies will be revised based on the findings of the different rounds to Delphi, then disseminated for public comment and digitally published once all comments are addressed followed by integration into Scope and Standards. An additional project arm is to conduct a national precision health and genomics nursing competency assessment to inform whether a national nursing genomic education initiative is required. The genomics questions will use the Genetic and Genomic Nursing Practice Survey (my instrument). Questions for precision health are being crafted and validated by the Precision Health team. Once completed with regulatory review and approval, the survey will be disseminated as a single instrument. The decision about education inventions will be determined based on the findings. A genomic implementation study will be conducted at Cedars Sinai building on my original MINC study and use the Roadmap and Maturity Matrix Tool. MINC-2 will be cancer focused and a phased project. Phase 1 will be conducted at the primary Cedars in Los Angeles. Phase 2 will roll out to all hospitals with cancer services within the Cedars conglomerate. This project will measure competency and implementation at baseline and at the conclusion of the study and compare usual hospital planned education/competency initiatives to the intervention same hospital. Cedars leadership approval is in place. A genomic post doc funded by NHGRI and ACMG has been with me and our Cedars collaborator B *TRUNCATED*